THE CONTRACTOR SHALL PROVIDE ONGOING DEVELOPMENT, MAINTENANCE, AND PROMOTION OF NCI SPONSORED BEHAVIORAL AND MOBILE HEALTH INITIATIVES.

The Contractor shall provide ongoing development, maintenance, and promotion of NCI sponsored behavioral and mobile health initiatives.